Enhancement of ADC selectivity by inverse targeting: Mechanistic studies and optimization

Cancer is a major cause of morbidity and mortality in the US, with 1.8 million cases and 600 thousand cancer
deaths projected for 2020. Substantial progress in cancer treatment has been made in the past two decades,
largely through the development of highly targeted therapies, including development of antibody-drug conjugates
(ADCs). ADCs employ monoclonal antibodies with specificity for tumor-associated antigens to increase the
efficiency and selectivity of the delivery of anti-cancer toxins (i.e., payloads) to cancer cells. Although this
approach has proven to be successful, with 9 anti-cancer ADCs approved for use in the US (brentuximab vedotin,
trastuzumab emtansine, gemtuzumab ozogamicin, inotuzumab ozogamicin, polatuzumab vedotin, enfortumab
vedotin, belantamab mafodotin, trastuzumab deruxtecan, and sacituzumab govitecan), ADC therapies are often
associated with substantial off-target toxicity, narrow therapeutic windows, and high failure rates in clinical
testing. This project introduces a new pharmacokinetic strategy to increase the tumor-selectivity of antibody-
directed delivery of anti-cancer drugs. In our approach, payload-binding antibody fragments, termed payload-
binding selectivity enhancers (PBSE), are co-administered with ADCs to decrease the exposure of healthy
tissues to payload agents, thereby reducing the development of off-target toxicity, increasing the tolerable dose
of ADCs, and increasing ADC efficacy. The strategy is based on the recognition that off-site ADC toxicity is
primarily attributed to the released (“free”) payload molecule, and also on the hypothesis that PBSE may be
employed to prevent cellular entry of free payload molecules in non-targeted cells (by preventing diffusion across
plasma membranes) without altering entry of ADCs into targeted cells (which proceeds via receptor mediated
endocytosis). Work in this project will focus on the development and evaluation of a novel series of PBSE that
have been shown to decrease the cytotoxicity of free SN38 and Dxd. These agents are camptothecin derivatives
that are employed as payloads for sacituzumab govitecan and trastuzumab deruxtecan, two recently approved
ADC molecules that have shown some efficacy, but substantial toxicity, in clinical investigations. Mechanistic
studies proposed in Aim #1 and Aim #2 examine relationships between PBSE molecular attributes (e.g., affinity,
molecular modality [i.e., IgG, Fab, scFv, sdAb], selectivity for unconjugated payload, molecular charge, etc.) and
PBSE utility in enhancing the pharmacokinetic and pharmacodynamic selectivity of ADC therapy. These findings
will be integrated through the use of mechanistic mathematical modeling to assist in the selection of an optimal
agent and dosing regimen for evaluation of efficacy and toxicity in Aim #3. The novel agents developed in this
work may be suitable for immediate translation toward optimization of sacituzumab govitecan and trastuzumab
deruxtecan therapy of refractory and resistant breast cancer.

Public health relevance
Narrative This project develops and tests a novel platform strategy that has been designed to reduce the undesired toxicity of antibody-drug conjugates (ADCs). Nine ADCs are currently approved for use in treating cancer in the United States, and more than 100 ADC agents are in current clinical testing. The strategy introduced in this proposal is expected to increase the tolerability of ADC therapy, allowing increased safety and efficacy in the treatment of cancer; if successful, the approach may be applied broadly, potentially providing benefit to large populations of cancer patients.